Biomarker Core

ABSTRACT – BIOMARKER CORE
The objective of the Biomarker Core is to acquire and analyze biofluid and imaging biomarkers, characterize
their relevance to Alzheimer’s disease (AD), and determine the underlying age-related factors that drive the
development, progression, or experience of the disease. To achieve these goals, we bring together experts
across diverse backgrounds in genomics, proteomics, metabolomics, and imaging to provide institutional
resources to serve ADRC investigators, help initiate new collaborations, and train the next generation of AD
and Alzheimer’s disease-related dementia (AD+ADRD) biomarkers researchers. Specifically, we propose
four aims: 1) Acquire conventional and novel biomarkers in biofluid (CSF, blood), brain images (PET, MRI),
and sensory organ data (retinal imaging) in adjudicated participant groups. Working closely with the Clinical
Core, we will acquire CSF, blood, PET and MRI biomarkers in our clinical cohort to submit to the National
Alzheimer’s Coordinating Center (NACC). At the same time, we will collaborate closely with independently
funded research projects to acquire novel and early biomarkers in high-risk populations during the prodromal
or early symptomatic stages of AD pathology. 2) Analyze biomarkers to obtain standardized measures and
support relevant funded research projects within the ADRC community. We will perform standardized
analyses in biofluid and imaging data to extract conventional biomarkers, and collaborate with existing
funded projects to develop specialized analytics to identify novel biomarkers that can lead to earlier detection
and prevention. 3) Provide resources to ADRC researchers integrating standardized multi-dimensional
biomarkers data across all participants to characterize the underlying age-related drivers for AD. Working
closely with the Data Management and Statistics Core, we will create and curate a multi-dimensional
database, integrating all acquired biomarkers and clinical measures. This database will be used to assist and
train the next generation of AD researchers in their investigations of underlying age-related drivers of AD,
through collaborations with the Research Education Component. 4) Disseminate our expertise and
knowledge to support the AD community at large. Working with the Outreach, Recruitment, and Engagement
Core, we will disseminate our expertise and knowledge on established and emerging biomarkers to the local
AD stakeholder community, other ADRC centers, and AD+ADRD researchers and providers across the
nation. Through these four aims, we hope to help achieve our overall objective to catalyze and support high-
caliber research and innovations to reduce the burden of AD and its impact on patients and families.